Optimal Ventilator Management in Patients with ARDS on ECMO

PROJECT SUMMARY/ABSTRACT
Research Plan: Acute respiratory distress syndrome (ARDS) is a severe and common condition that affects
10% of patients in the intensive care unit (ICU), and was a major cause of morbidity and mortality during the
COVID-19 pandemic. While mechanical ventilation is often necessary for ARDS, it can also induce additional
lung injury known as ventilator induced lung injury (VILI). VILI may be minimized by using low tidal
volumes/driving pressure and with positive end expiratory pressure (PEEP). Some patients with severe and
refractory ARDS require veno-venous extracorporeal membrane oxygenation (V-V ECMO), the highest level of
life support which provides oxygen and removes carbon dioxide from the blood using an external device. A major
benefit of ECMO is thought to be the ability to minimize VILI; however, the optimal ventilator settings for patients
with ARDS on ECMO are not known. Current guidelines use a one-size-fits-all approach. Our central hypothesis
is that personalized PEEP adjusted by measuring intrathoracic pressures via esophageal manometry (Pes) will
decease VILI as assessed by biomarkers of inflammation (main outcomes IL-6 and sRAGE). To carry out these
aims, we plan to prospectively randomize 62 patients with ARDS on V-V ECMO and neuromuscular blockade
and perform serial biomarker measurements with PEEP of 10 cmH2O (ECMO guidelines) vs. PEEP guided by
esophageal manometry. In addition to biomarkers of VILI, we will assess differences in other physiological
outcomes including pulmonary mechanics and gas exchange. Although this proposal focuses on patients on
ECMO, we believe the knowledge gained will have relevance for all patients with ARDS.
Career Development Plan: The goal of the PI, Dr. Mazen Odish, is to personalize ARDS and ventilator
strategies for those on ECMO based on physiology and biomarkers. The PI has an interest in applied physiology
and critical care, this award will help him refine these skills and develop new skills in clinical trials, statistics, and
patient-oriented research, to test rigorously methods to care for critically ill patients with ARDS with or without
ECMO. To obtain these new skills Dr. Odish and his excellent and multi-disciplinary mentoring/advisory team
(led by Drs. Owens and Malhotra, plus outstanding statistical and methodologic support) has three main training
goals. 1) Pulmonary mechanics and biomarkers during ARDS, 2) control of breathing and measurement of work
of breathing during ARDS/mechanical ventilation, and 3) clinical trial design and statistical training. These
training activities are tailored for the PI to achieve his goals and maximize career development towards becoming
an independent physician scientist. Furthermore, his structured course work will lead to a Masters of Advanced
Studies in Clinical Research. Dr. Odish is at the right place and time in his career to align his clinical expertise
in ECMO and ARDS with his research goals to understand optimal ventilator settings and therapies. Eventually
his work and new skill set may improve the lives of all people suffering from respiratory illness.

Public health relevance
PROJECT NARRATIVE While mechanical ventilation can be used to sustain life in those with lung injury, it, can further worsen lung injury or prevent lung healing resulting in high morbidity and mortality as seen in Acute Respiratory Distress Syndrome. Using extracorporeal membrane oxygenation (ECMO), the highest level of life support also known as the heart- lung machine, we can minimize injury from mechanical ventilation to allow the lungs to heal; however, the optimal ventilator strategies while on ECMO are unknown. This proposal will lay the groundwork for the PI to develop scientific expertise to guide personalized ventilator management even in the most severely ill patients (on or off ECMO), and ultimately for the PI to improve the lives of patients suffering from respiratory failure.